Place-Based Mapping in Electric-Acoustic Stimulation Listeners

Abstract
Cochlear implant (CI) recipients with acoustic hearing in the implanted ear are fit with a hearing aid and CI in
the same ear, a configuration described as electric-acoustic stimulation (EAS). While EAS supports better
performance than a CI alone, the benefit varies widely across individuals. One possible source of individual
differences is variability in the CI frequency-to-place mismatch, which is a discrepancy between the electric
filter frequency assigned to a particular electrode and the normal cochlear place frequency at the location of
that electrode. While prior studies have shown that tonotopic mismatch impacts speech perception in CI-alone
users, the impact of mismatch on EAS performance is poorly understood. Mismatch in EAS occurs because
current default mapping procedures use the patient’s unaided hearing thresholds in the implanted ear to
determine the lowest frequency filter assigned to electric stimulation and distributes higher-frequency
information logarithmically across the remaining electrodes irrespective of their location within the cochlea.
Mismatch is prevalent in EAS users due to wide variability in angular insertion depth (AID) across and within
electrode arrays, and variability in residual hearing. Mismatch occurs in two scenarios: 1) apical electrodes lie
basal to the acoustic cut-off frequency and deliver frequency information that is lower than their associated
place frequency, or 2) apical electrodes lie apical to the cut-off frequency and deliver frequency information
that is higher than their associated place frequency. In both scenarios, performance with EAS is likely hindered
by the mismatch between place of stimulation and natural tonotopicity of the cochlea. Performance in the latter
scenario could be further compromised by peripheral electric-on-acoustic masking. However, these problems
can be avoided if a patient’s acoustic hearing and electrode array AID are incorporated into EAS mapping
using a novel place-based mapping procedure. The proposed experiments evaluate a place-based mapping
procedure that uses postoperative computed tomography (CT) to calculate the AID of individual electrodes to
determine their cochlear place frequency. The electric filters are assigned to align with the associated cochlear
place frequency, resulting in a patient-specific map that eliminates frequency-to-place mismatch and minimizes
peripheral masking. We hypothesize that a place-based map will support better monaural hearing (e.g. speech
perception) in EAS users by limiting the need to acclimate to spectrally-shifted electric information while the
acoustic information is transduced in the natural place. Further, we expect that it will support better binaural
hearing (e.g. spatial release from masking) by providing an interaural match of frequency information between
ears. Benefits of a place-based map over a default map will likely be most apparent during the initial months of
EAS use when acclimatization to mismatch is occurring in the default case, and may persist longer-term for
those with the greatest degrees of mismatch. This project is expected to lay the groundwork for a novel and
clinically feasible mapping procedure to maximize performance for EAS users.

Public health relevance
Project Narrative The default mapping procedure for cochlear implant (CI) recipients does not consider the known variability in electrode array placement relative to the cochlear place frequency – creating varying degrees of frequency-to- place mismatch in the majority of patients. Frequency-to-place mismatch has been shown to negatively impact performance in CI users, and this may be particularly problematic for recipients with hearing preservation in the implanted ear who listen with an electric-acoustic stimulation (EAS) device because acoustic stimulation is resolved at the natural cochlear place, while the electric stimulation is spectrally-shifted. Proposed experiments will evaluate the use of a place-based mapping procedure that uses postoperative computed tomography to match the electric frequency filter of individual electrodes to their cochlear place frequency as a means to improving monaural and binaural hearing abilities with EAS.